UNTOLD: UNderstanding The experience of Ovarian cancer ? Life after Diagnosis: A Mixed Methods Approach

PROJECT SUMMARY
There are more than 250,000 ovarian cancer survivors in the US and this number is growing. Throughout
treatment for this disease, many patients encounter serious effects, including physical issues like nausea,
vomiting, fatigue, sleep disruptions, peripheral neuropathy, hair loss, and sexual dysfunction, as well as
psychological challenges such as cognitive dysfunction, fear of recurrence, anxiety, and depression.
Comprehensively understanding how the prevalence and severity of side effects, unmet needs, and barriers to
supportive care affect quality of life (QOL) in diverse ovarian cancer survivors remains a research gap and
priority. Our long-term goal is to improve the survivorship experience of individuals with ovarian cancer. Our
overall objective is to document 1) physical and psychosocial concerns, 2) barriers and facilitators to
supportive care, and 3) factors associated with unmet needs among ovarian cancer survivors. Our central
hypothesis is that ovarian cancer survivors face significant challenges, with differences in the frequency and
type of concerns by patient characteristics, e.g., time since diagnosis, age, race/ethnicity, sexual identity,
education, income, geographic location, and social support network. We will pursue the following specific aims:
(1) describe the physical and mental health conditions of ovarian cancer survivors that impact quality of life and
detail pharmacologic and non-pharmacologic interventions utilized to manage these conditions; (2) identify
barriers and facilitators to accessing and receiving supportive care among ovarian cancer survivors; and (3)
describe the unmet needs of ovarian cancer survivors and identify associated risk and protective factors
related to the number and types of unmet needs. We will use a mixed-methods approach. We will recruit a
diverse national sample of 2,000 ovarian cancer survivors in collaboration with the California Cancer Registry
along with regional and national ovarian cancer advocacy groups to complete a cross-sectional survey. Among
a subset, we will conduct follow-up interviews to gather additional information. The expected outcome of this
study is a comprehensive description of survivorship experiences among diverse ovarian cancer survivors.
This detailed information regarding their unmet needs and care gaps will serve as a call-to-action to develop
and implement targeted interventions to improve QOL of individuals with ovarian cancer. The proposed
research is innovative because we will assess outcomes in diverse ovarian cancer survivors, allowing for
subgroup analyses and we will identify care elements that contributed either negatively or positively to
survivors’ experiences. We expect our study will have a significant impact on informing effective strategies that
can be readily implemented and expanded to improve the QOL of cancer survivors, an explicit goal of Healthy
People 2030.

Public health relevance
PROJECT NARRATIVE Ovarian cancer is one of the leading causes of cancer death among individuals with ovaries and morbidity from the disease and its treatment is high. The overall objective of this proposal is to document the ongoing physical and psychosocial concerns, barriers and facilitators to care, and factors associated with unmet needs among ovarian cancer survivors. This research will have an important positive impact because identifying deficits in clinical and supportive care of ovarian cancer survivors is needed to design evidence-based interventions and public health programs to enhance the quality of life of cancer survivors.